IN VIVO TOXICITY TESTING OF COMPLEX MIXTURES

Assess methods for the in vivo toxicity testing of complex mixtures. Also consider and propose new research and development that is needed to improve the existing methods or devise new methods for testing and evaluation of mixtures of chemicals where such methods do not exist.